Addiction Training in Discovery, Computation, and Translation to Medicine

SUMMARY/ABSTRACT
During the past five years, major breakthroughs have occurred in discovery biologyy, computational “big data”
science, and translation to drug discovery that have not yet impacted the training of preclinical addiction
researchers. To address this gap, the present new predoctoral training grant uses a mentor mosaic model of
scientific training in the unique transdisciplinary, open culture of Scripps Research to develop a new generation
of leaders equipped with the new technical skills and expertise with team science needed to translate targets to
treatment. The training program is set in the historically successful addiction research environment at Scripps
and combines a core of expert mentors in the neuropsychopharmacology of addiction with pioneering partner
mentors in 4 other domains: a) discovery biology, b) computational and medicinal chemistry, c) advanced data
science and artificial intelligence, and d) translational medical science for drug discovery. An experienced Project
Director will be supported by impactful co-Directors in Biology and Chemistry, educational leaders from the
graduate school and other campus training grants, and a distinguished External Advisory Board of scientific and
mentoring experts dedicated to diversity. The mosaic scientific mentoring is supported by synergy with addiction
and translational training grants at Scripps for more senior career stages, new translational curricula in advanced
data science at Scripps and UC-San Diego, distinguished seminar series in each key discipline, reverse
mentoring through SANDI summer internships, peer-to-peer mentoring for career development, and both didactic
and experiential opportunities to enhance leadership, writing and grantspersonship, oral communication, ethical
science, and rigor and reproducibility. A recruitment plan is detailed to attract diverse young scientists to apply
to work with the 30 experienced, well-funded mentors at all career stages. The training plan has the potential
to yield a new type of addiction researcher – skilled in team science and with transdisciplinary fluency not
only in neurobiology, but also big data science and leading-edge approaches in discovery biology and
chemistry.

Public health relevance
NARRATIVE The present application from Scripps Research proposes to train the next generation of addiction researchers using in a mentoring mosaic not only in the neuropsychopharmacology of addiction, but also in modern discovery techniques, advanced data science and artificial intelligence, and translational drug discovery .The transdisciplinary scientific training and new career development experiences are driven by a team of experienced mentors, supported by educational and scientific leaders in Internal and External Advisory Boards. The novel training aims to yield new breed of addiction researcher, fluent in new wet lab, dry lab, and team building techniques to translate targets to treatment.